Mechanistic Insights into Catalytic Acyl C-O and C-N Activation and Cross Coupling

PROJECT SUMMARY/ABSTRACT
Transition metal-catalyzed cross-coupling methods are important in the context of human health because they
play a central role in the synthesis of small-molecule therapeutics and molecular probes. Although cross-coupling
methodologies are dominated by palladium catalysis, newer methodologies utilizing terrestrially abundant 3d
metals (such as nickel) enable cross-coupling with polar C–O and C–N electrophiles. This feature is important
because O- and N-containing functional groups are common in bioderived and bioactive small molecules and
could therefore offer a greatly expanded scope of sustainably sourced cross-coupling partners. However, nickel
catalyzed methodologies for cross-coupling with acyl C–O and C–N electrophiles remain in early stages, and (i)
face practical limitations due to a pronounced sensitivity to changes in substrate structure, (ii) generally require
high precatalyst loadings, and (iii) often utilize high reaction temperatures or long reaction times. Attempts to
address these limitations are stymied by a lack of detailed mechanistic into the features responsible. This
proposal addresses these ambiguities through systematic mechanistic investigation of three distinct classes of
nickel-catalyzed cross-coupling with biologically important acyl C–O and C–N electrophiles with a specific focus
on (i) C–X activation steps, (ii) selectivity-determining features, and (iii) speciation of key organometallic
intermediates. This approach leverages ligand design and organometallic synthesis, structure elucidation
through spectroscopic and crystallographic studies, and reaction kinetics, supported by state-of-the-art
computational analysis to derive insights into the reactivity and selectivity-determining features of catalytic
reactions. These insights will be leveraged to elucidate key reactivity and selectivity relationships and to offer
methodological improvements that address current inefficiencies. As an Early-Stage Investigator (ESI), the PI is
uniquely suited to build this research program due to their extensive prior experience working across the organic–
inorganic and synthetic–mechanistic axes to interrogate, improve, and invent methodologies with translational
potential. The PI’s program will build on this expertise to offer conceptually innovative, mechanism-driven,
strategies to meet key synthetic needs. Successful completion of the proposed research will result in detailed
insight into the mechanisms and limiting features of nickel-catalyzed acyl C–N and C–O activation and cross
coupling. These insights will be translated into development of a suite of single-component precatalysts with
enhanced activity and selectivity along with a practical “user’s guide to catalyst selection” to enable expanded
application to the synthesis and elaboration of biologically important small molecules. The ultimate goal of this
project area is to achieve mechanism-driven improvements bringing these methodologies—which use
terrestrially abundant metals to elaborate biologically abundant functional groups—to a level competitive with or
superior to established, palladium-catalyzed cross-coupling alternatives.

Public health relevance
PROJECT NARRATIVE The nickel-based cross-coupling reactions evaluated in this proposal utilize a terrestrially abundant metal catalyst to elaborate amide and ester functional groups prevalent in biologically derived and bioactive molecules. This project is relevant to the public health mission of the NIH because it will establish the critical insights necessary to develop these transformations into the next generation of practical tools for the efficient, selective, and environmentally benign preparation of pharmaceuticals for the study and treatment of human disease.